Dynamic Bone-Implant Loading in Osseointegrated Prostheses

PROJECT SUMMARY
An osseointegrated prosthesis is a novel alternative to a prosthesis socket that directly mounts the prosthesis
to the residual limb through a bone anchored implant, which improves the load transmission between the ground
and residual limb. Proper loading at the bone-implant interface is critical to long-term outcome as underloading
can lead to implant loosening and overloading can lead to periprosthetic fracture. Preliminary outcome evidence
is highly promising regarding improvements in function and quality of life following prosthesis osseointegration
compared to a traditional socket; however, mechanical failure due to implant loosening or fracture persists in a
small subset of this population, which can have devastatingly negative impacts on the patient.
Although bone-implant loading has a direct impact on outcome, it cannot be measured in-vivo. As a result,
finite element models are the most widely used surrogate to estimate bone-implant loading. However, these prior
models have three primarily limitations that impede their clinical utility: 1) they have not included activities of daily
living, 2) they have not incorporated muscle forces, and 3) they have not been developed for transtibial
osseointegrated prostheses. The first goal of this proposal is to leverage an existing dataset that will
develop a state-of-the-art modeling platform that will quantify bone-implant interface loading in patients
with transfemoral and transtibial osseointegrated prostheses during activities of daily living.
Rehabilitation following prosthesis osseointegration involves progression of mechanical loading through
gradual increase in weight bearing and strengthening exercises designed to promote bone remodeling to prepare
the bone and implant to sustain loads required for daily living. Further on in the healing stage, gait retraining is
prescribed to retrain the movement patterns of the patient as they habituate to the new ability to directly load the
residual bone. Although rehabilitation is pivotal to optimize patient outcome, it remains hindered by a lack of
empirical data that results in protocols being not well defined, lacking validation, and not specific to amputation
level. The second goal of this proposal will be to establish the effects of simulated rehabilitation on bone-
implant interface loading in patients with transtibial and transtibial osseointegrated prostheses.
This proposal will be the first to quantify dynamic bone-implant interface loading in osseointegrated
prostheses while incorporating subject-specific movement, muscle, and joint forces (Aim 1) and to assess the
effects of rehabilitation on these loading patterns (Aim 2). Because mechanical failures are largely due to
pathologic loading at the bone-implant interface, understanding how it is altered by amputation level, activity,
and rehabilitation following prosthesis osseointegration is critical to optimizing outcomes in this population. As
prosthesis osseointegration gains in awareness, evidence regarding its effect on the musculoskeletal system is
critically needed to make this promising prosthesis more accessible to a broader population.

Public health relevance
PROJECT NARRATIVE Osseointegrated prostheses are a novel alternative to a socket prosthesis that directly mount the prosthesis to the residual limb femur via a bone anchored implant, which allows the amputated limb to be loaded in a more normative fashion. Early evidence is highly promising regarding the improvement in function and quality of life after osseointegration; however mechanical failure due to implant loosening or periprosthetic fracture caused by pathologic loading at the bone-implant interface exists in a small subset of this population, yet the mechanistic understanding as to why remains poorly understood. The findings of this proposal will be fundamental in the understanding of bone-implant loading mechanics and failure mechanisms, which can be used to improve the efficacy of targeted post-surgical rehabilitation by normalizing loading following prosthesis osseointegration.